Next generation calcium channel modulators

Project Summary
Timothy syndrome (TS) is a rare, multisystem disorder caused by a mutation within the CaV1.2 L-type Ca2+
channel. Despite considerable research, treatment for TS remains limited and often results in death in early
childhood due to severe long-QT syndrome and cardiac arrythmia. Thus, there is a critical need for increased
understanding of pathogenesis, and development of new treatment options for TS. While most TS mutations
cause gain-of-function (GOF) effects on the channel, when broken down by channel property the mutations
cause a spectrum of biophysical changes, differentially effecting channel activation, voltage-dependent
inactivation (VDI) and Ca2+-dependent inactivation (CDI). By CRISPR-generating induced pluripotent stem cell
(iPSC) lines harboring multiple distinct TS mutations, we will greatly expand the number and variety of iPSC
models available to study pathogenesis and treatment. These models will enable new resolution of the role of
CDI, VDI and activation in shaping the cardiac AP in physiological and pathological states, and in modulating
drug efficacy, enabling informed decisions on the benefits and limitations of calcium channel blockers (CCBs) in
the treatment of TS. Moreover, TS pathogenesis is exquisitely modulated by channel splice variation. In most
patients, the mutation occurs within either mutually exclusive exon 8a (TS1) or 8 (TS2), resulting in distinct
phenotypes dependent on the distribution and expression level of the affected variant. Splice variation is a critical
and often overlooked contributor to pathogenesis, and we propose a complex interplay between channel splicing
and TS pathogenesis. We hypothesize that expression of exons 8 and 8a are not uniform across the heart, and
that variable expression of a mutant-containing exon leads to increased APD dispersion, and exacerbation of
arrhythmogenesis in TS. Moreover, we propose that TS mutations perturb splice expression in the heart.
Exploring the complex interplay between TS and splicing represents an important direction for understanding
pathogenesis and may provide an opportunity for treatment. We propose that antisense oligonucleotide (ASO)
mediated switching between exons 8 and 8a has the potential to significantly improve the cardiac function and
life expectancy of TS patients harboring a mutation in either of the 2 alternative exons. By targeting channel
splicing, ASOs are predicted to reduce the APD dispersion caused by non-homogeneous splicing, further
reducing the arrhythmogenic potential of TS mutations. We will therefore utilize iPSC derived cardiomyocytes
harboring TS mutations to reveal the capability of ASOs to overcome the arrhythmogenesis of TS in the context
of APD dispersion. Further, we will utilize a newly developed TS2 mouse model to demonstrate the ability of
ASOs to rescue the LQT phenotype in-vivo. As non-uniform splice variant distribution is likely to challenge the
treatment of any channelopathy in which a mutation is expressed within a mutually exclusive exon, ASOs
represent a powerful personalized medicine approach beyond TS.

Public health relevance
Project Narrative Timothy syndrome is a severe genetic disorder caused by a mutation within a calcium channel that disrupts the normal electrical signaling of the heart and often leads to fatal cardiac events. By exploring the role of splice variation in modulating the mechanisms underlying Timothy syndrome, we will gain insight into the challenges and opportunities for treatment of the disease. We propose that antisense oligonucleotides will be able to overcome the challenges caused by variations in channel splicing, resulting in a new treatment option for Timothy syndrome patients.